New Biotechnology using MicroRNA Inhibitors to Regenerate Alveolar Bone

Summary/Abstract Dental implants are becoming an increasingly popular option vs. dentures, bridges, and other dental prosthetics due to greater patient satisfaction and better long-­term outcomes. However, osseointegrated dental implants require strong, healthy bone for implantation to be successful. While success rates for osseointegrated dental implants are relatively high (~90%), a drastic increase in the number of implantation procedures is expected to occur due to the increasing popularity of the procedure with patients and clinicians, as well as demographic factors such as an increased number of aging and elderly patients that require dental prostheses. Failed dental implantations can lead to a significant cost and care burden to patients and to the healthcare system, and initial failures often mean that additional attempts at implantation in the same site are not possible. Together, these factors signal the need for a clinical tool that will increase the rate of osseointegrated dental implant success, particularly in patients who are at higher risk for failure due to the inadequate presence of high-­quality bone in which to place the implant. NaturemiRI, LLC has developed a novel method of microRNA (miR) inhibition using a biologically native molecule composed of nucleic acids with a unique secondary structure, allowing it to bind and degrade or sequester mature miRs. The inhibition of binding mature miRs to their mRNA targets alters protein production in the cell. It has been established in our preliminary studies and previously published reports that miR-­200a inhibits osteogenic differentiation and increases the pro-­inflammatory response. Our Phase I project goal is to demonstrate that by inhibiting miR-­ 200a in vitro and in an animal model, we can increase rates of osteogenesis and enhance the quality of regrown bone. During Phase I, we will analyze bone hardness, mineral content, and density during osteogenic differentiation and in an artificial wound-­healing model. We also intend to demonstrate that the nucleic acid based composition of our inhibition method negates the risk of systemic toxicity—a concern that exists with the use of synthetically modified oligonucleotide miR inhibition methods. Phase I success will set the stage for a larger Phase II demonstration project focused on larger-­scale testing and validation of the envisioned new tool for the dental clinic—an anti-­miR-­200a-­infused collagen sponge that could be used in tooth extraction procedures in anticipation of future osseointegrated dental implantation. Success will also establish therapeutic proof of concept for this new miR inhibition method, ultimately opening the door for an important range of additional therapeutic applications in the dental field and beyond. NaturemiRI’s experienced team of dental researchers is established and well-­suited to address the scientific questions regarding the proposed application. NaturemiRI leadership also includes a small but experienced business development team that is working diligently on commercialization activities regarding the many potential applications of this technology.

Public health relevance
Project Narrative Nearly 70% of adults ages 35- 44 have lost at least one permanent tooth, and by age 74, 26% of adults have lost all of their permanent teeth. Although dental implants have about a 90% success rate, an aging population and the trending increase in the number of these procedures necessitates that additional work be done to improve success rates and mitigate adverse health effects that can arise from implantation failures. This SBIR project is focused on a new technology designed to significantly reduce implant failures by stimulating alveolar bone regeneration, improve healthcare outcomes and quality of life while reducing treatment costs.